Mechanistic Studies of NAD+/NADH in Human Heart Failure

Project Summary/Abstract
Mitochondrial dysfunction and energy deficiency have been strongly implicated in the development of heart
failure (HF). Yet, the exact mechanisms remain poorly understood and mitochondria-targeted therapy is
lacking. Recently, a causal relationship between the loss of cardiac NAD(H) homeostasis and mitochondrial
dysfunction has been proposed in HF. The NAD(H) redox balance, i.e. NAD+/NADH ratio, is a critical regulator
of multiple enzymatic reactions in cell metabolism. NAD+ also functions as a co-substrate for sirtuin deacylase,
ADP-ribose transferases, and cyclic ADP-ribose synthases that post-translationally modify proteins; including
enzymes important for energy transduction and cell signaling. In prior studies, we and others have observed
lower NAD+/NADH ratio and elevated protein acetylation (LysAc) in cardiac tissue from mice and human
patients of advanced HF. Importantly, increasing NAD+ levels by pharmacological or genetic approach
normalized the loss of NAD(H) redox imbalance and reversed mitochondrial protein hyperacetylation leading to
improved cardiac function in multiple animal models of HF. In the preliminary studies, we have demonstrated
that oral NR supplementation significantly increases whole blood NAD+ levels and improves peripheral blood
mononuclear cell (PMBC) oxidative metabolism in humans. While these studies provide us the unique
advantage of moving the translational research forward, two major gaps in our knowledge remain to be
addressed. One is that no study has addressed the critical questions of whether oral NR increases NAD+ levels
in the myocardium of HF patients. The other is that the mechanisms by which increasing NAD+ level benefit HF
is unclear. Therefore, here we propose to determine whether oral NR supplementation for eight days prior to
surgery can increase NAD+ levels and improve mitochondrial function in human failing myocardium obtained at
the time of left ventricular assist device (LVAD) implantation. We hypothesize that participants randomized
to NR will have higher myocardial NAD+ levels, improved mitochondrial function and reduced
inflammatory response as compared to participants randomized to placebo. Preliminary data from a non-
randomized Pilot Study of NR pretreatment prior to LVAD implantation suggest that NR does, in fact, increase
myocardial NAD+ levels, improve mitochondrial function in PBMCs and myocardium, and decreases
inflammatory response gene expression in PBMCs. The randomized study proposed in this application also will
examine the effects of increasing intracellular NAD+ level on mitochondrial and non-mitochondrial
compartments, including epigenetic modifications and regulation of inflammation, as well as correlate these
changes in myocardium with corresponding changes in blood. Confirmation by this study of the anticipated
effects of NR on human myocardium would represent an important advance in investigating the potential of NR
as the first, mitochondria-targeted metabolic therapy in heart failure.

Public health relevance
Project Narrative Preliminary animal studies by ourselves and others suggest that the dietary supplement, nicotinamide riboside (NR), may improve cardiac function in heart failure (HF) by increasing cellular levels of its metabolite, NAD+. This Study will address a key gap in current knowledge by assessing the mechanisms through which raising blood and myocardial NAD+ levels in humans mediates changes in mitochondrial function, protein and epigenetic modifications, as well as inflammation. Human myocardium will be obtained after 4-14 days of oral NR supplementation from advanced heart failure patients undergoing elective left ventricular assist device (LVAD) implantation. If the results are positive, this would provide evidence to proceed with further studies of NR as the first, mitochondria-targeted metabolic therapy in heart failure.